A multiregional RCT of Parenting in 2 Worlds for Urban Indian Families

Project Summary/Abstract
A large and rapidly growing majority of American Indian/Alaska Native (AI) families now reside in urban areas.
Although they experience severe health disparities associated with substance abuse, risky sexual behavior,
depression and suicide, few evidence-based prevention interventions address their distinctive needs. Family
disruption, stresses due to migration and poverty, and cultural and social losses are often implicated in adverse
health outcomes for urban AI families. By improving effective parenting skills and overall family functioning,
culturally grounded parenting interventions enable parents to model and promote their children's well-being
and reduce their children’s vulnerability to risk behaviors. The proposed study extends the project team's prior
research on a culturally grounded parenting intervention for urban AIs, Parenting in 2 Worlds (P2W), which
was co-developed with a coalition of urban Indian non-profit organizations, tested in three Arizona cities, and
demonstrated efficacious. The research team joins two AI and two non-AI investigators, who together have
extensive experience conducting collaborative research with AI populations in urban and tribal settings. This
proposed multi-regional study will create new knowledge in four areas. First, the study will test P2W’s
effectiveness beyond Arizona in improving parenting and family functioning, among a wider and more diverse
group of urban AI communities located in cities spread across four regions: Northeast (Buffalo/Niagara),
Midwest (St. Paul/Minneapolis), Mountain (Denver), and Southwest (Phoenix). Through the auspices of
collaborating urban Indian center partners, the trial will recruit 720 families of AI youth age 12-17 (180 per city)
and individually randomize them to receive P2W or an informational family health curriculum. Second, the
study will test for moderators of the effectiveness of P2W, whether desired outcomes vary by the level of
socioeconomic vulnerability, experiences of historical loss, or AI cultural identity of the parent participants.
Third, the study will expand on the original Arizona trial to examine the adolescent’s reports on family
functioning and an enlarged range of youth health behaviors potentially impacted by the P2W intervention,
including mental health (depressive symptoms, suicidality) as well as substance use and risky sexual
behaviors. Fourth, the study will test for mediation—whether positive changes in parenting and family
functioning that result from P2W lead to changes in the youth health behaviors. This would be the first cross-
site multiregional trial of a culturally grounded parenting intervention designed specifically for urban AIs. It will
advance critical knowledge on community prevention interventions for an under-served group severely affected
by health disparities, and establish whether urban Indian centers and their communities can readily employ
P2W to strengthen urban AI families and promote the behavioral health of their youth. It will also provide a
foundation for advancing knowledge on effective prevention interventions in urban AI communities that have
different migration histories and tribal compositions.

Public health relevance
Public Health Impact Statement The proposed study responds to a need for innovative culturally grounded parenting interventions to serve diverse urban American Indian/Alaska Native (AI) communities across the nation and address unacceptably high levels of substance use, risky sexual behavior, depression and suicidality among urban AI youth. This study will test whether a parenting intervention proven efficacious in one state is effective in distinctive and geographically dispersed urban AI communities. It will also demonstrate whether the intervention prevents youth risk behaviors through improvements in parenting skills and family functioning.